Optimizing RNA import for microinjection-free genetic manipulation in C. elegans

Project Summary
C. elegans is amenable to easy genetic modifications, as proven by its pioneering and continued use of
endogenously expressed fluorescent reporters and other genetically encoded molecular tools. CRISPR/Cas
systems for generation of mutants and transgenic lines are widely used in C. elegans. While highly precise,
CRISPR/Cas applications are severely limited by the need to microinject nucleic acids to the germline, a
significantly time-consuming process that drastically hinders the use of C. elegans for high-throughput biology.
On the other hand, C. elegans has the ability to uptake double stranded RNA by feeding, which has led to the
generation of dsRNA-expressing bacterial libraries and their use for large-scale reverse genetic screens. In this
project, we aim to address this important limitation in C. elegans by developing a strategy that enables
microinjection-free CRISPR/Cas applications. We will develop an approach to efficiently deliver RNA by feeding
throughout C. elegans tissues for use as single-guide RNA (sgRNA) in CRISPR/Cas systems. Our approach
relies in using easily uptaken RNA carriers to facilitate efficient import of sgRNAs through ingestion. We propose
to address this challenge by: 1) studying uptake of diverse RNA structures into different C. elegans tissues
through the development of an RNA sensor strain, 2) designing RNA structures for optimal uptake using artificial
intelligence, and 3) testing the efficacy of modified sgRNA structures in CRISPR/Cas applications. Success of
this work will greatly facilitate implementation of CRISPR/Cas approaches and make large-scale high-throughput
CRISPR screens possible.

Public health relevance
Project Narrative: Model organisms, such as the nematode C. elegans, are crucial to understand fundamental biological processes. While CRISPR/Cas approaches for genetic manipulation are efficient and widely used in C. elegans, microinjection is a significant technical hurdle that prevents large scale implementation. In this project, we will engineer RNAs that can be imported from the environment by C. elegans and that can be used in CRISPR/Cas systems for microinjection-free genetic editing.